Innovative technology for elimination of microbubbles during hemodialysis treatments

Project Summary
Around 400,000 patients in the US and at least 5 million world-wide, receive weekly sessions of hemodialysis
(HD), the standard long-term treatment for irreversible kidney failure. Although it has revolutionized the field by
increasing the longevity of patients, improvements in the technique and equipment have been stagnant for
decades. Besides from still suffering from high premature mortality rate compared to the general population, HD
patients carry a high burden symptomatology which requires frequent hospitalizations and significantly
deteriorate the patient’s overall quality of life. It is agreed upon that a major contributor to the patients’ symptom
burden arises from the HD treatment itself. The main difficulty in identifying and eliminating bio-stressors that
arise from the HD treatment is that most of them appear to be minute low intensity imperfections of the procedure
that only cause health problems because of the frequent and cumulative exposure time (>600hrs/year) to which
HD patients are subjected to. One of these stressors considered as an unavoidable hazard of the HD treatment
is air microbubble infusion. Microbubble infusion by HD affects mostly the lungs- causing endothelial damage,
atherosclerosis, pulmonary vascular remodeling, and dyspnea- but have also been found in the heart and brain
of patients. There is currently no technique or technology capable of eliminating from HD the majority of
microbubbles of sizes below 100 µm. SIL Technologies is proposing an acoustically expedited microbubble
diffusion technology that would eliminate most, if not all, microbubbles present in the extracorporeal tubing of
HD equipment. The proposed technology uses acoustic forcing to “push” microbubbles against the wall of a
silicone tube which is gas permeable. The silicone tube is surrounded by degassed water. The combination of
acoustic forcing and gas concentration difference (between air bubble and degassed water) provide a strong
diffusion driving force, capable of working even through thick membranes (thicknesses larger than 0.5 mm). We
expect to prove the feasibility of the technology by completing the following specific aims: i) An acoustic
resonance chamber will be designed to maximize the acoustic force and bubble-diffusion anchoring sites by
finite-element simulations. ii) The device designed in i) will be constructed and in-line installed to a fluid circuit
powered by a peristaltic pump and filled with a transparent blood mimicking fluid. Pulse-Doppler microbubble
counters will be placed at the entrance and exit sites of the device to collect the necessary data to determine the
effectiveness of the concept. And finally, iii) the fluid circuit will be filled with real blood and the experiments
carried out in ii will be repeated. A statistical analysis of the effectiveness of the device operating on blood will
be determined as well as basic blood cell integrity tests to have a preliminary safety assessment of the proposed
technology.

Public health relevance
PROJECT NARRATIVE Microbubbles infusion to patients undergoing hemodialysis treatment (450,000 in the US) is a well identified/unsolved issue responsible for a number of additional medical conditions that such patients develop (contributing to their well known high morbidity). SIL technologies proposes to apply innovative approaches proven valid to treat other bubble-presence-in-blood diseases (like Decompression Sickness) to address a solution to this problem. A device able to eliminate microbubbles injected from hemodialysis apparatuses will be demonstrated feasible through this project.